Interoceptors controlling airway constriction

Project Summary
Asthma, characterized by airway inflammation, airflow obstruction, and airway hyperresponsiveness, is
an increasingly common inflammatory airway disease that affects 10% of the world's population. Given that anti-
inflammatory treatment only partially controls asthma symptoms, it is urgent to understand the involvement of
non-immune systems in the disease. Emerging evidence suggest that lung interoceptors, sensory nerves
monitoring the internal states, play a key role in the development of asthma symptoms. Our recent studies
discovered that MrgprC11+ jugular sensory neurons control cholinergic bronchoconstriction and airway
hyperresponsiveness. Ablation of MrgprC11+ neurons reduced airway hyperresponsiveness without affecting the
allergic inflammation in a mouse asthma model. Furthermore, our preliminary data suggest that asthmatic
cytokines modulate the neuronal activity of MrgprC11+ neurons and sensitize cholinergic bronchoconstriction. In
this proposal, we will use Cre-dependent labeling, transcriptomic, epigenomic, and mouse airway mechanic
analysis combined with a novel calcium imaging technique to investigate how MrgprC11+ neurons contribute to
airway hyperresponsivness in asthma. Aim 1 will focus on the transcriptomic and epigenomic analysis of
MrgprC11+ neurons in asthma to understand how lung interoceptors respond to allergic airway inflammation.
Aim 2 will investigate how the airway inflammation modulates the electrophysiological properties of MrgprC11+
neurons and changes the neuronal responses of airway-innervating nerves. In Aim 3, we will investigate the
neuro-immune interactions between MrgprC11+ nerves and asthmatic cytokines and examine if these
interactions contribute to airway hyperresponsiveness. These studies will reveal novel neural mechanisms
controlling asthma symptoms.

Public health relevance
Project Narrative Asthma, accompanied by lung inflammation, bronchoconstriction, and airway hyperresponsiveness, is a significant public health burden. Although recent basic and clinical research has led to a better understanding of the immunological mechanisms of asthma, the neural mechanisms underlying asthma symptoms remain unclear. This proposal aims to investigate how vagal sensory neurons contribute to asthma symptom.